Biological Imaging Module

Biological Imaging (BI) Module
Summary
The Biological Imaging (BI) Module provides state-of-the-art equipment and resources for
histological analysis and analytical imaging of biological tissues, for training vision research
investigators in the use of these technologies, and to promote new collaborative studies among
established and emerging investigators. Specific Aims are: 1) To provide state-of-the-art
super-resolution technology for analytical imaging of ocular and neural tissues, which are
beyond reach of individual laboratories. 2) To provide training for new investigators and staff on
advanced imaging techniques in super-resolution semi-automated confocal microscopy,
deconvolution and 3D imaging software and other module equipment and digital graphics
production. 3) To promote research of early stage investigators and foster interactions and
collaborations among a university-wide, multi-cultural, diverse vision research community. The
BI module was extensively used in the last grant cycle and was essential for promoting
innovative vision research, including testing efficacy of novel therapies, developing and
validating viral expression vectors for gene therapy projects, investigating receptor-ligand
interactions during disease, identifying biomarkers and validating proteomics/metabolomics
data, as described below. BI module equipment was expanded in the last year to include new
confocal microscopy systems, live retinal imaging and sensitive protein analysis. The BI module
has been used to generate data that was reported in numerous publications and included in
new grant awards and R01 applications from established and recently hired faculty. The module
also facilitated recruitment of a new faculty member (Dr. Pham) who will be a heavy user of the
confocal live imaging system. This module will continue to provide an essential resource for
translational and basic science research for investigators of the McKnight Vision Research
center (MVRC).